Mechanisms of hypersensitivity to sound-induced cochlear damage

Project Summary All information about the acoustic environment is carried from the inner ear to the CNS by the afferent fibers of the cochlear nerve. Rapidly gating AMPA glutamate receptors (AMPAR; GluA2, GluA3 and GluA4 subunits) mediate synaptic transmission at the mature synapse between the inner hair cells (IHC) and the afferent fibers of the cochlear nerve (IHC synapse). However, the contribution of each type of AMPAR subunit to overall glutamatergic receptor function and afferent transmission/sensitivity in the cochlea is poorly understood. Understanding this process is important because glutamate excitotoxicity through AMPAR has been implicated in the pathogenesis of hearing loss caused by noise, ischemia and aging. Sex differences in the vulnerability to hearing loss occur in humans. We therefore began investigating the contribution of AMPAR subunits to transmission at the IHC synapse and whether there are sex-specific differences in AMPAR subunits that contribute to sound-induced cochlear damage and hearing loss. Based on functional and ultrastructural preliminary data, we now hypothesize that “GluA3 AMPAR subunits have a critical role in the sexually dimorphic vulnerability to hearing loss”. To define mechanistically how GluA3 contributes to the structural and molecular components of IHC synapses and to sex differences that underlie the hypersensitivity to sound-induced cochlear damage, we will use a powerful combination of functional (ABRs, DPOAE), immunocytochemical (confocal microscopy, STED), biochemical and ultrastructural approaches to test the following hypotheses. In Aim 1, we will determine whether the absence of GluA3 leads to aberrant AMPAR complexes at IHC synapses along the tonotopic cochlear axis. In Aim 2, we will determine whether if, in the absence of GluA3 and resulting increase in GluA2-lacking receptors, ambient sound levels lead to sex differences in the excitotoxicity of IHC synapses and hearing loss. Aim 3, based on published data and our preliminary findings, we propose the hypothesis that in the absence of GluA3, ovarian hormones facilitate the hypersensitivity to sound-induced cochlear damage, while androgens have protective effects. Proposed studies at the first glutamatergic synapse in the auditory pathway, will address the important research question of how changes in AMPAR subunit composition lead to sex differences in hearing loss.

Public health relevance
Project Narrative AMPA glutamate receptor subunits have been implicated in the pathogenesis of hearing loss, however, their role in afferent transmission/sensitivity in the cochlea is poorly understood. The proposed studies at the first sensory synapse in the auditory pathway will address the important question of how changes in AMPA receptor subunit composition lead to sex differences in hearing loss.